DATA COORDINATING CENTER OF THE NATIONAL CAPD REGISTRY

Provide data management support to the Clinical Coordinating Center (CCC) of the National Continuous Ambulatory Peritoneal Dialysis (CAPD) Registry for the management and operation of a national voluntter CAPD patient registry. Forthe purpose of obtaining data on this maintenance therapy for chronic uremic patients, data collection and analysis willinclude: certain demographic characteristics of CAPD patient incidence of peritonitis; survival of patients in this therapy; mortality; morbidity; frequency of hospitalizations; rehabilitation status; transfer to other therapies; and selected other data.